Host inflammatory response to SARS-CoV-2

Each year, humans encounter a variety of seasonal corona viruses that cause minor symptoms similar to the
common cold. In contrast, SARS-CoV-2, which is responsible for COVID-19 (coronavirus disease 2019), has
caused more than 110,000 deaths in the United States alone as of June 4, 2020. For unknown reasons, COVID-
19 disease severity is extremely variable, with many infected individuals experiencing mild symptoms including
sore throat, headache, and cough or no symptoms at all. However, a significant number of infected individuals
experience severe disease, including acute respiratory distress syndrome, renal failure, cardiac arrest, and
gastrointestinal distress. Importantly, SARS-CoV-2 infection can trigger a hyperactive immune response that
results in a cytokine storm, which is a massive release of pro-inflammatory molecules that can cause fatal tissue
damage and likely causes the most severe disease symptoms. What triggers and regulates a cytokine storm is
unclear, and studies are needed to reveal the processes by which SARS-CoV-2 induces inflammation, and how
SARS-CoV-2 infection imparts COVID19 disease. Thus, the overarching goal of this proposal is to determine
how inflammatory responses to SARS-CoV-2 are generated. To address this goal, we propose the following
Specific Aims:
1. Define the inflammatory cytokine response induced by SARS-CoV-2. We will evaluate cytokine
production from cells infected with SARS-CoV-2 using cell lines derived from lung and immune cells that populate
the lung. Additionally, because severe COVID-19 patients present with elevated levels of the cytokine IL-1β and
because IL-1β is released following the inflammatory form of cell death known as pyroptosis, we will assess the
ability of SARS-CoV-2 to stimulate pyroptosis. We will then use CRISPR-based gene knockout and
pharmacologic inhibitors to map the molecular pathways required for production and release of the observed
cytokines.
2. Determine the inflammatory transcriptome across infected and bystander cells in propagating and
amplifying inflammatory responses to CoV2. Using single cell RNA sequencing, we will assay mixed
populations of cells with infected and non-infected (bystander) cells to determine how virus infection imparts
inflammatory gene expression and how inflammatory signals from infected cells affect neighboring uninfected
cells to amplify the inflammatory response. Sequencing and bioinformatics analyses will be conducted by the
Gale lab transcriptomics and computational biology team, and results will be validated by complimentary
techniques.
From these studies, we expect to reveal the inflammatory cytokine signaling events following SARS-CoV-2
infection. These studies will also provide biomarkers to identify patients susceptible to cytokine storm and will
identify gene or gene network/pathway targets to inform strategies to treat COVID-19 disease.

Public health relevance
Studies in this proposal are focused on defining the inflammatory response to SARS-CoV-2 infection. Results from this work will define the cell signaling programs and genes that respond to SARS-CoV-2 infection to drive inflammation that imparts COVID-19 disease. These studies will identify biomarkers and gene networks to predict inflammatory responses and to identify strategies to ameliorate severity of COVID-19 disease.